ADVANCING INFECTIOUS DISEASES DETECTION AND RESPONSE IN INDONESIA THROUGH IMPROVING PUBLIC HEALTH LABORATORY CAPACITY

PROJECT SUMMARY
The purpose of this proposal is to conduct high quality public health research projects in
Indonesia that will be beneficial in defining national and sub-national health policies. In the 1st
year, the projects will focus on:
1. Understanding the prevalence of hospital acquired infections (HAIs) toward establishing a
high-quality antimicrobial resistance (AMR) surveillance in Indonesia. This project will
enable MoH to identify the prevalence of HAI and the results will be used to assist the
planning for infection prevention and control interventions and case management.
Additionally, results will support the MOH to develop a standardized and informed
response to address HAIs in Indonesia;
2. Detecting priority infectious diseases of interest to Indonesia as well as evaluate
diagnostic assays through the establishment of novel laboratory capacity. Initially, the
primary focus of this study will be on malaria and the specific aims of this study are to
determine the prevalence of Plasmodium in one targeted area and to evaluate the RDT
for the diagnosis of malaria using serology techniques;
3. Evaluating the capacity needed at national reference, provincial, and district laboratories
to strengthen laboratory systems for the effective detection, testing, diagnosis, and
reporting of selected epidemic prone diseases of importance to Indonesia. Results of this
study will be used to provide recommendations and develop a strategy to improve the
laboratory testing capacity and sample referral system in Indonesia.

Public health relevance
(1)Point Prevalence Survey of Healthcare Associated Infection (HAI) in Indonesia to identify the prevalence of HAI will be initially piloted in two hospitals: Adam Malik hospital in Medan and Sanglah hospital in Denpasar. (2)Assessing Malaria Transmission in Endemic Area of South Kalimantan-Indonesia will be conducted to determine the prevalence of malaria in Tabalong District, South Kalimantan province and to evaluate the RDT for the diagnosis of malaria using serological approaches. (3)Specimens Referral Study data will be collected from hospitals and laboratories at selected provinces to assess the laboratory testing capacity and specimen referral system, map the system and identify key components of the system.